Physician dispensing of oral specialty drugs for advanced prostate cancer and its implications for patients

PROJECT SUMMARY
Nearly 35,000 succumb to advanced prostate cancer each year, making it the second leading cause of cancer
death among men. The development of oral specialty drugs targeting specific molecules has led to a paradigm
shift in which men can receive treatment for their prostate cancer at home. Oral specialty drugs, such as
abiraterone and enzalutamide, have similar efficacy as physician administered chemotherapy with less toxicity
and are the most common first-line treatment for advanced prostate cancer as of 2015. This new treatment
paradigm has been accompanied by concurrent changes in in the delivery system. Increasingly, prescriptions
for oral specialty drugs are dispensed directly by the urologist or medical oncologist in their office (referred to
as “physician dispensing”). Patients may benefit from this delivery model as it places the onus for authorization
and identification of financial assistance on the prescribing physician. Combined with the integration and
coordination implied by dispensing at the point of care, this delivery model may improve access, timeliness and
adherence to these specialty drugs. However, financial incentives associated with physician dispensing,
through a margin generated by each prescription fill, may foster prescribing behaviors promoting utilization that
undermine the value of this delivery system change, such as use of these therapies in patients with preexisting
conditions that predispose them to adverse drug effects. To understand the implications of this delivery model
for patients, we propose the following: (1) To measure the effects of physician dispensing on use of specialty
drugs for prostate cancer; (2) To determine the impact of physician dispensing of specialty drugs for prostate
cancer on financial outcomes and coping behaviors; and (3) To measure the relationship between physician
dispensing of specialty drugs for prostate cancer and patient safety. Results from this study will have real-world
implications for men with advanced prostate cancer, who are naturally interested in getting the highest quality
cancer care while avoiding the financial consequences commonly associated with oral specialty drugs.

Public health relevance
PROJECT NARRATIVE This study will assess the effects of physician dispensing of oral specialty drugs (i.e., dispensing of medications directly to patients by the physician) for advanced prostate cancer on utilization, financial consequences, and safety. Results from this study will have real-world implications for men with advanced prostate cancer, who are intent on getting the highest quality cancer care while avoiding financial consequences and toxicity associated with these medications.